Synthesis of Natural Products by Oxidative Dearomatization and Discovery of BRAT1 Degraders

Proposal Summary
Quaternary carbon centers are vital for the structural diversity of organic compounds, impacting
the biological activity of natural products, pharmaceuticals, and materials. This proposal aims to
develop oxidative conditions for the dearomatization of substituted phenols and achieve the total
synthesis of Lycopodium alkaloids, with a focus on magellaninone and related alkaloids. The
feasibility of manipulating product stereochemistry will be explored. Additionally, the total
synthesis of curcusone A-D and the identification of potent BRAT1 degraders will be pursued.
Synthetic protocols will be built upon, using readily available aromatic precursors. Molecular
interactions between curcusone D and BRAT1 will guide the design of efficient protein degraders,
with attachment point and linker modifications investigated. This research will advance the field
of oxidative dearomatization and contribute to the development of novel therapeutic strategies.

Public health relevance
Project Narrative Quaternary carbon centers are vital for the structural diversity of organic compounds, impacting the biological activity of natural products, pharmaceuticals, and materials. This proposal aims to develop oxidative conditions for the dearomatization of substituted phenols and achieve the total synthesis medicinally relevant natural products and drug candidates.